P21-activated kinase 1 is a novel regulator of cardiac and adipose tissue function in females

Project Summary
Experiments proposed in this K01 aim to investigate a novel role of PAK1 in the regulation of cardiac
function and adipose tissue homeostasis in female mice. The specific aims are: Aim #1 To investigate the
mechanisms by which estrogens regulate PAK1 in the heart and adipose tissue. Aim #2: To investigate
the mechanisms by which PAK1 regulates cardiac function in female mice. Aim #3: To investigate the
mechanisms by which PAK1 regulates adipose tissue homeostasis in female mice and the effect of its
dysregulation on cardiac function. The scope of the research planned for this supplement is to study the
effects of FTY720 (fingolimod) in a model of heart failure linked to obesity and hypertension.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) and obesity are more frequently seen in postmenopausal women but causes of these conditions are not clear. Work proposed in this grant aims to test the overall hypothesis that P21-activated kinase 1 (PAK1) regulatory activities in the heart and the adipose tissue are governed by estrogens and that PAK1 dysregulation, due to decreased estrogen levels, affects cardiac and adipose tissue function. These studies will explain, at least in part, the higher incidence of HFpEF and obesity in women and will provide new targets for future therapies.